Molecular Mechanism by which Notch Signaling regulates TMJ Osteoarthritis

The Temporomandibular Joint (TMJ) is the most-used joint in the body. The TMJ cartilage carries out
the essential function of enabling free joint movement during speech and mastication. TMJ
Osteoarthritis (TMJ-OA) consist of osteochondral tissue degeneration and is a growing epidemic that
afflicts men and women not only in United States but across the globe. It is well established that
altered expression and activation of catabolic enzymes underlies joint cartilage destruction observed
in TMJ-OA, however the precise mandibular chondrocyte behavior during TMJ cartilage degeneration
and regeneration is not well understood.
Notch signaling has been identified as a potential catabolic and anabolic mediator of TMJ-OA.
Understanding Notch cellular signaling that regulate osteochondral tissue degeneration can lead us to
development of new therapeutic targets. To sufficiently advance our understanding of Notch signaling
in TMJ degeneration-regeneration and translate our findings, will require robust experimentation,
including preclinical studies in TMJ degeneration model. Our long-term goal is to develop a clinically
relevant approach to modulate Notch signaling to prevent TMJ degeneration and facilitate its
regeneration. Our central hypothesis is that Notch ligand (Jagged 1 / 2) is a potential target for TMJ-
OA, and they work via upregulation of bone morphogenetic protein 2 (BMP2) and Indian hedgehog
(Ihh) signaling pathway. This work will be completed in three specific aims, using novel mouse model
and state of art genomic technology. Our preliminary work has demonstrated that Jagged 1 is
significantly over expressed (both mRNA & protein) in TMJ degeneration both in mice and humans. In
specific aim 1, we will disrupt Jagged1/2 in lineage specific manner in chondrocytes and osteoblasts
of subchondral bone. In specific aim 2, we will define the pathophysiological mechanism by which
Notch ligand (Jagged 1 / 2) leads to TMJ degeneration and regeneration at single cell level and in
specific aim 3, our experiments will translate our mechanistic observation and study the role
Jagged1/2 plays in traumatic TMJ injury and repair, specifically using anti-Jagged 1 antibodies to
reduce TMJ degeneration.
The proposed project has immense potential to reveal new regulatory pathways that modulates TMJ
degeneration and regeneration and to open new insights on understanding the disease mechanism
and developing therapeutic interventions.

Public health relevance
Degenerative disorders of Temporomandibular Joint (TMJ) are painful and debilitating diseases, affecting over 20 million people in United States. Notch ligand and notch receptors have been implicated in joint cartilage and subchondral bone homeostasis, but little is known about their roles in the TMJ-OA. This proposal aims to understand how Jagged1/2 ligands and BMPR signals controls cellular and molecular events behind TMJ- OA. Additionally, it will also test the efficacy of neutralizing Jagged1 antibody in alleviating TMJ-OA.